Effects of age at marriage and education on health of mothers and children

STATEMENT OF WORK
Field work and data collection will be performed by Project Associates at IPA Bangladesh. Project design,
oversight and data management and analysis will be the shared responsibility of the Co-investigators and their
staff at J-PAL/MIT and Duke University.
A postdoctoral fellow will work in close cooperation with Erica Field and contribute to the strategic direction of
the survey instruments. She will also work closely with the full-time research assistant on data analysis and
contribute to writing the academic paper.
Professor Erica Field, Co-Investigator, will lead project design, oversight and analysis, in addition to writing of
an academic paper for submission to top economics journals. Her experience in randomized control-treatment
research design, financial services for the poor, health interventions in low-income countries, managing large-
scale field experiments abroad, and development economics more broadly will make her a valuable contributor
to the project.
Under the direct supervision of Professor Erica Field a full-time Graduate Research Associate will contribute to
project design and be primarily responsible for developing the survey instruments and conduct the pilot studies.
In addition, the Graduate RA will support field management and data collection.
A full-time Office Research Associate under the direction of Professor Erica Field will be primarily responsible
for the cleaning, management and analysis of data collected by the field team in Bangladesh. The Research
Associate’s duties will include cleaning and scrutinizing incoming data and organizing it into a functional
database. The Research Associates will perform statistical and econometric analysis and assist in the
preparation of manuscripts, grant reports, and related documents. The RA will also support field work
management and data collection.
Research Manager Lauren Faber will coordinate with counterparts at IPA Bangladesh and IPA Headquarters in
New Haven, CT to lead project coordination and oversee project finances and administration.

Public health relevance
NARRATIVE This project examines the long-run health impacts of reducing child marriage and increasing human capital. It is a continuation of a project that experimentally varied the age of first marriage and human capital through financial incentives and empowerment training. This phase of the project will rigorously assess, using objective health measures, the impact of delayed marriage and increased human capital on women’s long-term physical, reproductive, and psychological health as well as the impact on their children’s health and well-being.